A Platform Technology to Genetically Reprogram Cancer Cells for Enhanced Immunotherapy

PROJECT SUMMARY
Advances in cancer immunotherapy have great potential for treating tumors that are refractory to
conventional treatments, and T cells primed ex vivo by natural or artificial antigen-presenting cells (APCs) to
target and kill cancer cells have been shown clinically to improve survival in patients with highly aggressive
cancers. APCs normally prime T cells by presenting a tumor antigen-specific signal 1, consisting of a major
histocompatibility complex (MHC) I molecule with a tumor antigen peptide; a co-stimulatory signal 2 that directs
the action of the T cells upon recognition of the tumor; and a secreted signal 3 for recruitment and activation of
immune cells. Instead of engineering the patient's APCs to direct a T-cell response against a tumor or fabricating
artificial, synthetic APCs, both of which are costly, complex, and/or patient-specific processes, we propose to
reprogram cancer cells themselves to become tumor-associated APCs (tAPCs). Because tumor cells
already intrinsically express signal 1 (tumor antigen in the context of MHC I), they can be engineered in situ to
express the other necessary signals and therefore act as APCs, directing cytotoxic T-cell responses against
themselves. Tumor cells with low MHC I expression will stimulate natural killer (NK) cells to aid this purpose. We
have designed synthetic, non-viral nanoparticles that can deliver DNA to cancer cells with high efficacy and
specificity over healthy tissue, and we will inject these into a tumor mass to induce expression of signal 2 and
signal 3, using two different in vivo orthotopic tumor models (melanoma and triple-negative breast cancer) and
four in vitro tumor models as examples. Having optimized a nanoparticle formulation with anti-cancer efficacy
after intratumoral injection in local and metastatic cancer models, we will further this strategy during the R37
extension period by co-delivering a gene cassette to locally express checkpoint inhibitor antibodies, following
our discovery in the first phase of the R37 that our nanoparticles (1) synergize with systemic checkpoint inhibition
and (2) prevent immunotoxicity of systemic immunotherapies by sequestering gene expression primarily to the
local tumor. We will further discover new genetic pathways leading to susceptibility and resistance to this
immunotherapy strategy via comparative transcriptomics across different tumor types, allowing us to apply the
new knowledge to the development of even more successful immunomodulatory gene therapies. This extension
remains within the initial scope of the project, which focused on local therapy and immunological analysis thereof,
but broadens its goals by further innovating on the platform technology developed in the first phase. If successful,
this could result in an affordable, fully synthetic, local, antigen-agnostic therapy that nevertheless leads to
antigen-specific systemic immune rejection of a wide range of different tumor types.

Public health relevance
PROJECT NARRATIVE Non-viral gene delivery nanoparticles are used to reprogram cancer cells into tumor-associated antigen- presenting cells (tAPCs) to help train the immune system to recognize relevant antigens. This R37 extension will expand the initial grant's work by co-delivering immunotherapeutic genes based on results discovered in the initial phase of the project as well as using additional analytical tools to broaden the applicability of this technology. This will lead to an innovative off-the-shelf technology and will also elucidate the biological mechanisms underlying this novel treatment strategy.